Applying a multidimensional measure of human mobility to understand drivers of HIV incidence in Rakai, Uganda

PROJECT SUMMARY/ABSTRACT
Background. As sub-Saharan African (SSA) countries embark on the last mile toward HIV elimination, HIV
programs must prioritize hard-to-reach mobile populations at the greatest risk of HIV acquisition and onward
transmission. Some differentiated service delivery models may work for mobile people, but targeting services to
such a broad category of individuals could waste limited resources. Since it is unclear which forms of mobility
most significantly increase the risk of HIV infection, this study aims to systematically characterize mobility and
relate it to HIV incidence at both the individual and sexual network levels. Aims. In line with NIMH Human
Mobility and HIV program objectives to determine incidence rates and examine HIV outcomes among mobile
populations, this study will 1) characterize mobility and its association with HIV testing and viral load suppression,
2) estimate HIV incidence by mobile group, and 3) determine the effect of mobility on the risk of HIV acquisition
in sexual networks. Elucidating these gaps will inform future targeting and tailoring of interventions to improve
the health of mobile populations. Approach. Since no consistent measure for mobility exists across HIV studies
in SSA, this research will use detailed mobility metrics from the Rakai Community Cohort Study (RCCS), a
population-based longitudinal study in south-central Uganda where there is substantial human movement, to
develop a multidimensional measure that considers the frequency, duration, motivation, and spatial dimensions
to people’s movement. This measure will uncover subclasses of mobility that can be linked to HIV incidence and
other prevention and treatment outcomes. RCCS data from 19,300 adults aged 15-49 will be supplemented with
data from Hard-to-Reach (HTR), an embedded study within the RCCS that captures HIV outcomes and mobility
patterns among 2,000 individuals who have been lost to follow-up (LTFU) in the RCCS. This presents a unique
opportunity to assess the missing data biases introduced by population mobility in open, dynamic cohorts. Each
Specific Aim will use the full extent of the available data, including longitudinal HIV biomarkers and detailed
contact investigations conducted among HIV incident cases and their HIV-negative matched controls. Training.
Ms. Khalifa’s training plan leverages her quantitative abilities and HIV research experience to advance her skills
and launch her into a career as an independent investigator focused on mobility and health. Her training goals
are to develop in-depth knowledge of mobility and migration, gain experience with longitudinal survey methods,
learn advanced epidemiologic techniques for missing data and network analyses, and build capacity for effective
research dissemination. Under the guidance of her Primary Sponsor, Ms. Khalifa will receive tailored mentorship
from a team of experienced HIV researchers who work with the parent studies, conduct mobility-focused
research, and have tremendous expertise in the requisite quantitative methods. Training will take place at
Columbia University, a high-caliber institution with specialized research programs in population health, infectious
disease, and spatial and social epidemiology.

Public health relevance
PROJECT NARRATIVE Mobile populations experience higher rates of HIV acquisition and inadequate access to health services in sub- Saharan Africa, yet HIV programs are still ill-equipped to meet the needs of specific mobile groups. Since population movement also facilitates the spatial spread of the virus, HIV programs working towards elimination must target and tailor services to mobile populations at the greatest risk of HIV acquisition and onward transmission. This study will characterize distinct forms of mobility in south-central Uganda, an area with substantial population movement, and relate each to critical gaps in the HIV response.